Data-driven discovery of host-microbiome protein-protein interactions

Research Summary
Despite numerous large-scale metagenomic case-control studies that associate microbial taxa and
genes with specific diseases, surprisingly little is known about the molecular mechanisms underlying these
associations. Much of the mechanistic microbiome research to date cites the production of small molecules,
immune interactions and indirect interactions with food or drugs. However, direct protein-protein interactions
(PPIs) have emerged as a novel facet of host-microbiome interaction underlying microbiome-associated
disorders. Building from an initial analysis of host-microbiome PPIs that leveraged existing PPI databases, we
have now expanded this approach to predict novel host-microbiome PPIs. We have applied protein language
models to develop a novel commensal host-microbiome interaction prediction (CHIP) tool. Our final model is
capable of screening through the 1011 possible host-microbiome PPIs with high precision, albeit low sensitivity.
This initial step cuts down on the search space, enabling refinement steps on a much smaller subset, using
structure prediction models, such as AlphaFold-multimer. This proposal aims to further develop our pipeline
and validate it computationally and experimentally. Our overall goal is to accelerate data-driven and
experimental discovery of host-microbiome PPIs. Our first aim is to further improve our CHIP model and
analyze the host-microbiome interaction network. Our second aim is to utilize structure predictions, specifically
focusing on interfaces, to infer functions. As shared interfaces between PPIs or protein-molecule interfaces
suggests a common underlying function, we will examine whether microbiome proteins bind human proteins at
important sites vis à vis the interactor's human protein binding partners. Our third aim is to apply proximity
labeling to identify novel host receptor-bacterial protein ligand interactions, addressing a major gap in the
existing data on host-microbe PPIs. Our fourth aim is to validate subsets of the host-microbiome interaction
network that represent important hubs involving proteins situated within disease-relevant pathways. These
include investigating the role of host-microbiome PPIs in intestinal barrier integrity, ubiquitination pathways,
and inflammation signaling pathways. Overall, we aim to vastly expand our annotations of microbiome-derived
proteins in human disease-relevant pathways. We anticipate these findings will lead to the identification of
novel therapeutics, diagnostics and drug targets.

Public health relevance
Research Narrative Direct interactions between human and microbiome proteins are increasingly recognized for their role in various microbiome-related disorders. Discovery of human-microbiome protein-protein interactions (PPIs) has thus far been opportunistic, raising the question of whether these interactions are widespread and, if so, what impacts they have on host physiology. We outline a computational PPI discovery pipeline that scans the entire potential human-microbiome interactome for high-confidence PPIs, building evidence based on interfaces, differential abundances in metagenomic case-control cohorts, and functional annotations, as well as an experimental PPI discovery platform, accelerating the development of microbiome-inspired therapeutics.